The AMPDECIDE Patient Decision Aids: Empowering Veteran Participation in Personalized Amputation Level Decision-making

The choice of amputation level among Veterans facing amputation secondary to diabetes and/or peripheral
artery disease can have profound effects on many functional outcomes. Informing patients of their likely key
functional outcomes (i.e., mortality, reamputation, restoration of mobility) at each amputation level, enables them
to pursue outcomes consistent with their values and priorities and provides an opportunity to spend the remaining
functional life years maximizing quality of life. Patient decision aids (PtDAs) have been identified as important
tools to enhance this process by serving as catalysts to engage patients in shared decision-making (SDM)
processes; however, with respect to amputation level, patients have historically not participated in the decision-
making process. The fundamental goal of the proposed research is to enable Veterans facing a dysvascular
lower extremity amputation to participate in amputation level decision making, by informing them of their
personalized outcome risks at each amputation level, and by assisting them in determining their outcome
priorities and preferences. Since each amputation level is associated with different functional outcomes and
competing healing risks, PtDAs that offer patients their unique, personalized outcomes will help ensure that the
chosen level aligns with a patient’s unique priorities and preferences, thereby contributing to optimal function,
quality of life (QoL), and participation in community activities that are important to them. Our research team has
developed a physician-facing AMPREDICT Decision Support Tool (DST) that predicts the individual patient
specific risk of 12-month mortality, reamputation, and independent mobility at each major lower extremity
amputation level (transmetatarsal (TM), transtibial (TT) and transfemoral (TF)), which has now been successfully
integrated into the VHA electronic health record (EHR). We have also developed patient-facing non-personalized
AMPDECIDE TM/TT and TT/TF PtDAs that present population average risks, rather than personalized risks;
these are currently housed in the AMPDECIDE web portal which is external to the EHR. Pilot results evaluating
usability and feasibility of the PtDAs indicate that 54% of patients would have preferred to make the final
amputation level decision and 27% indicated they would have preferred to share in the decision with their
provider, leaving a very small proportion who would not want to participate in amputation level shared decision
making. Further, nearly all patients expressed interest in learning about their personalized outcomes. To achieve
the known benefits of SDM engagement, an emerging opportunity is to incorporate decision making tools into
the EHR; PtDAs integrated into the EHR demonstrate high and sustained adoption rates. This study involves the
development and validation of the technology to create personalized PtDAs available within the EHR by
integrating them with the personalized risks generated from the AMPREDICT DST, allowing Veteran patients
facing amputation to view the personalized aids within a clinical encounter, presenting a tremendous opportunity
to engage in the amputation level decision, which will lead to functional, QoL, and participation outcomes that
align with patients’ priorities and preferences for their remaining life years. More specifically, the goals of this
grant are threefold. First, we will develop and validate the technology to create personalized AMPDECIDE patient
decision aids that provide individual patient specific risks of key functional outcomes at each major lower
extremity amputation level. Access to the decision aids through the EHR will facilitate point of care access.
Second, we will evaluate the efficacy of the personalized AMPDECIDE PtDAs, compared to standard of care, in
improving patient knowledge and reducing decisional conflict (primary efficacy measures), regarding their
personal trade-offs of each amputation level. Secondary efficacy measures will include improvement in shared
decision making, decisional satisfaction and impact on QoL. Finally, we will identify barriers and facilitators to
implementation of the personalized AMPDECIDE PtDAs through a formative evaluation with provider participants
and key stakeholders, which will guide implementation of the AMPDECIDE tools VA-wide.

Public health relevance
The choice of amputation level among Veterans facing amputation due to poor circulation can have profound effects on many outcomes, including quality of life (QoL). Informing patients of their likely key functional outcomes (i.e., mortality, reamputation, restoration of mobility) at each amputation level, enables them to pursue decisions consistent with their values and priorities and spend their remaining life years maximizing QoL. Patient decision aids (PtDAs) are important tools to enhance this process by encouraging patients to participate in shared decision-making. However, most PtDAs provide average risks, which may not reflect the risks of a specific patient. We intend to develop personalized amputation level electronic PtDAs that can be viewed at the point of care with a medical provider and evaluate their efficacy at improving patient knowledge and QoL, as well as decreasing decisional conflict for both patients and providers. We will also collect important implementation information so that at the completion of the study, the personalized PtDAs can be implemented across VHA.